EleGantry: a software and hardware infrastructure to improve rigor and reproducibility within invertebrate research

PROJECT SUMMARY/ABSTRACT
Caenorhabditis elegans is a mainstay of biomedical research and its growth as a model is likely to only
increase in time. In particular, C. elegans is used with great effect to study neuronal circuitry, cell development
and aging. However, as its use has increased, challenges with using C. elegans as a model have also made
themselves more evident. One particularly noteworthy challenge is the variability between studies in reported
wildtype animal lifespan, a common endpoint across disease models. Although it is conventionally known that
C. elegans under normative growth conditions live an average of 3 weeks, a recent meta-analysis of C. elegans
publications found that reported average ages ranged from 7 days to 35. The majority of C. elegans publications
report only minimal methodological and environmental data and concluded that most variation could be ascribed
to the accumulation of many small variables that often go unreported. As such, there is currently an unmet need
in the C. elegans aging field for a system to better improve the methodology of how C. elegans experiments are
conducted through removal of sources of variance and additional data recording and reporting.
Ora Biomedical, Inc. is a longevity biotechnology company that identifies and develops small molecule
healthy aging therapeutics using large-scale, unbiased, live animal phenotypic analysis with lifespan as a primary
endpoint. We use custom built, fully scalable, automated state-of-the-art robotics and machine learning AI
combined with health and survival analysis to perform high-throughput preclinical gerotherapeutics development
that far surpasses the competition. With robust preclinical discovery at the heart of our approach, we identify
novel aging targets and new interventions for known targets. Importantly, we leverage large-scale operations to
perform drug-drug interaction studies to identify lifespan intervention combinations that produce breakthrough
increases in healthy lifespan.
The overarching goal of this SBIR proposal is to use massively high-throughput preclinical drug testing in a
non-mammalian model system to identify compounds that extend organismal lifespan and/or effect the
progression of age-associated diseases. The specific goal of this SBIR Phase I proposal is to develop EleGantry,
a tool that will meet the need for improved rigor and reproducibility in C. elegans drug-discovery through
increased depth of data collected and automation of several key steps of the standard C. elegans pipeline. These
targeted steps that have a disproportionate large effect on the quality of C. elegans experimentation and
subsequently are often key sources of variability between studies. Additionally, EleGantry will allow the reporting
and publication of all of this valuable information so that replication of research and additional validation is made
as effective and efficient as possible.

Public health relevance
PROJECT NARRATIVE C. elegans is one of the most widely used animal model systems yet many studies fail to be reproducible due in large part to poor data recording and variations in methodological and environmental variables. To improve rigor and reproducibility, we are building a novel laboratory tool (EleGantry) that will increase collection and reporting of critical data and eliminate several key sources of human error that lead to increased variability. This Phase I proposal will consist of developing the physical platform that will record images of animal populations and environmental data under normal laboratory conditions, the software suite to analyze and report data as well as remove several sources of human error, and a large benchmark dataset consisting of a natural products screen.